RANDOMIZED, MULTICENTER DOUBLE BLIND PHASE III STUDY--ZDV, ZDV/DDC OR SAQUINAVIR

This study will enroll patients naive to anti-retroviral therapy or who have received less than 16 weeks of ZDV. Additionally, it will compare the safety, tolerance, and efficacy based on clinical endpoints of: 1) ZDV; 2) ZDV + ddC; 3)ZDV + saquinavir and 4) ZDV + ddC + saquinavir. The purpose of this protocol is to test if saquinavir (proteinase inhibitor) will interfere with growth of HIV in the body and to test whether saquinavir is safe to take for at least 80 weeks.